A Novel Melanoma Vaccine Based on a Shared Neoantigen and a Liquid Polymer Platform

ABSTRACT
Despite the dramatic improvement in outcomes afforded by immune checkpoint inhibitors and targeted
therapies, most patients with metastatic BRAF-mutated melanoma ultimately experience progression of their
disease. One key reason for resistance to immune checkpoint inhibitors is a paucity of melanoma-specific T
cells, but unfortunately, the majority of early melanoma vaccines meant to expand melanoma-specific T cells
have failed to demonstrate benefit. Next generation sequencing and in silico peptide-HLA binding prediction
have allowed investigators to vaccinate cancer patients against neoantigens – peptides that are not expressed
by any normal tissues but are only found in tumors. Although neoantigen vaccines hold great promise, a key
limitation is the fact that neoantigens are generally private, thus it is not possible to make an “off-the-shelf”
neoantigen vaccine that will be appropriate for a large group of patients. We and others have found that
melanoma patients can mount an endogenous T cell response to a mutated BRAF (valine to glutamic acid at
position 600). We have further demonstrated that an HLA-A2-binding mutated BRAF peptide (mBRAFp) is
highly immunogenic in HLA-A2-transgenic mice. Here we propose that an immunogenic vaccine targeting
V600E-mutated BRAF in the context of HLA-A2 has the potential to expand melanoma-specific T cells. As a
shared neoantigen, mBRAFp is a relevant tumor target for approximately 20-25% of melanoma patients (40-
50% of melanoma patients harboring BRAF V600E x 50% of patients harboring HLA-A2). This off-the-shelf
therapeutic vaccine may be used as a monotherapy for patients with high-risk resected melanoma or with
minimal tumor burden. It may also be combined with anti-PD-1 for patients with melanoma that is refractory to
immune checkpoint inhibitor therapy and targeted therapy. Our vaccine consists of mBRAFp and resiquimod
(RSQ) as adjuvant formulated in CAPRO™ - a new class of proprietary biodegradable liquid polymers,
providing local controlled release of both the antigen and adjuvant. Previously we found that (1) mice
vaccinated with ovalbumin (OVA) and RSQ loaded in CAPRO developed long-lasting OVA-specific antibody
and CD8 T cell responses, and (2) CAPRO-loaded mBRAFp and RSQ elicited antigen-specific T cell response
in HLA-A2 transgenic mice. Based on these promising results, we have initiated preclinical product
development program involving CMC of the vaccine ingredients and formulation development and have
received written comments from the FDA in response to our pre-IND inquiry. The goal of this project is to
define the vaccine product and set the stage for full CMC and pharmacology/toxicology studies toward an IND
application. To accomplish this goal, we will first evaluate the prophylactic and therapeutic antitumor efficacy
and safety of our vaccine product in a mBRAFp-expressing HLA-A2 transgenic mouse model with direct
comparison with a formulation using Montanide (a clinically used vaccine adjuvant system). We will also
explore the potential of combining vaccine with immune checkpoint inhibition (anti-PD1). We will then develop
analytical assays for vaccine ingredients and final vaccine product, and generate IND-enabling data to meet
CMC requirements of the FDA.

Public health relevance
PROJECT NARRATIVE Combining a mutant BRAF peptide – the only known shared melanoma neoantigen with a novel biomaterial platform, this collaborative project between clinical oncology and biomaterial engineering may ultimately lead to clinical translation of an effective off-the-shelf therapeutic vaccine with significant positive impact on the lives of 20 to 25% of all melanoma patients.